Core A: Administrative Core

Summary
The primary goal of the Administrative Core is to ensure productivity of the Program by promoting coherence
and synergy as well as intellectual and resource sharing, among the PIs and their lab members in order to ensure
that the outcome and value of the research performed in each Project is greater than the sum of its parts. This
Core will facilitate and coordinate the following activities that are essential for the success of the entire Program:
research planning and scientific review, monitoring progress relative the proposed Program goals, data
exchange, reagent and animal/tissue sharing, travel to annual Program meetings and between PI labs, and
reporting and fiscal oversight. Thus, Core A will provide the structure and organization needed to maximize
interactions and collaboration among the PIs and lab members in each of the three Research Projects, Core B
and Core C, which will, in turn, facilitate accomplishment of Program goals.
Based on past experience, we believe that the key to effective collaboration is direct personal interactions.
Three of the five labs are in the Austin area. Dr. Manley’s group is at the University of Georgia. Drs. Hale and
Sempowski are at Duke. As Drs. Manley and Richie know from working together for nearly 20 years, travel
between Athens and Austin is relatively inexpensive with multiple direct flights available on a daily basis.
Similarly, traveling from Raleigh/Durham to Austin is straightforward. Personnel travel between labs facilitates
achieving scientific objectives, and is in some cases necessary for the proposed experiments. Lab member
exchange is the most effective mechanism for transfer of techniques between labs. All three Research Projects
will exchange lab members to achieve specific scientific goals. Travel to annual Program lab summits and
scientific meetings provides for efficient communication of results to each other and to the scientific community,
and affords the ability to learn new approaches and gain information to shape future work. Also, this is an efficient
and effective way for all lab members to meet and discuss data together. While face-to-face meetings are an
invaluable method of communication, in a geographically distributed collaboration they are of necessity limited
in scope. We are already engaged in and will continue web-based conferencing that permits multi-site visual and
audio communication, and facilitates analyzing data and images collaboratively.
General administrative functions will provide vital additional levels of cohesion and facilitate program
productivity. While most administrative assistant related support will continue to be supplied by the home
institutions of each PI, Core A will perform any such services requiring coordination between the Research
Projects and Cores.